IAFF HazMat Worker Health & Safety Training

The International Association of Fire Fighters (IAFF) addresses critical issues related to hazardous materials incidents and emergency response through specialized training programs. The IAFF enhances the skills and knowledge of first responders handling and responding to hazardous materials and natural or man-made disasters, ensuring their safety and improving community outcomes. Objectives: Equip emergency responders with comprehensive knowledge and practical skills to manage hazardous materials and technical rescue emergencies safely; Train emergency responders for effective response strategies and tactics during complex emergencies; Address emerging threats and adopt new technologies to keep communities and first responders safe.
Specific Aims: Enhance the capabilities of emergency response workers by delivering current or updated firefighter safety and health training programs; Identify specific first responder organizations and communities at risk of encountering or being affected by HazMat incidents; Maintain evaluation protocols to gauge training effectiveness and ensure the program meets and exceeds the NIEHS Minimum Training Criteria Document; Enhance, revise, or develop educational materials and conduct training sessions to increase the effectiveness of HazMat response efforts.
The IAFF targets firefighters, emergency medical workers, disaster relief workers, public health workers, and law enforcement. Annually, the IAFF will deliver 52 classes and train 1,300 workers, addressing the needs of emergency responders in both urban and rural areas across the United States. IAFF training programs emphasize the importance of addressing emerging threats and include training on the latest hazards, such as renewable energy sources and energy storage systems. By incorporating cutting-edge technologies, such as virtual reality simulations and advanced detection equipment, including Unmanned Aerial Vehicles (UAVs), this training effort ensures that participants are well-prepared for today’s threats.
The benefits include a reduced risk of accidents and health issues associated with hazardous material exposure; Improved public health by minimizing hazardous material-related injuries and deaths; Highly trained emergency workers who can effectively respond to emergencies and protect communities.

Public health relevance
Overall Project Narrative: The International Association of Fire Fighters (IAFF) is committed to preparing first responders and communities to confront environmental and hazardous waste threats by providing them with the tools, knowledge, and skills needed to protect their health and safety. By partnering with NIEHS, federal stakeholders, as well as collaborating at the state and local level with law enforcement, emergency management, and EMS, we ensure our training programs meet top standards and effectively prepare communities and first responders to mitigate hazardous substance risks. The IAFF will address these issues by continuing to deliver and improve the training and education of first responders, utilizing innovative technologies for preparedness and response, and addressing emerging threats to protect first responders and the communities they serve.